Regulation of T cell memory in tissue immunity

Program Summary/Abstract
Tissue-resident memory T cells (TRM) are crucial for the frontline defense against pathogen infection and
maintenance of tissue homeostasis. How T cells are fated for TRM development and targeted for residency in
specific tissue sites remain poorly understood. The environmental cues that orchestrate metabolic adaptation for
TRM development or maintenance are also unclear. These knowledge gaps represent substantial barriers to
harnessing the full therapeutic potential of TRM cells in infectious disease and cancer. In our preliminary studies,
using in vivo pooled CRISPR screening of mitochondria and lysosome-associated genes, we uncovered
organelle signaling and metabolic processes shaping CD8+ TRM development. Specifically, three nutrient-
dependent lysosomal signaling nodes, Flcn, Rag GTPases and Ragulator, potently inhibit TRM formation.
Depleting these molecules or depriving amino acids activates transcription factor Tfeb, thereby linking nutrients
to TRM programming. Further, Flcn deficiency promotes protective TRM responses against gastrointestinal
pathogen infection. Mechanistically, Flcn restrains retinoic acid-orchestrated tissue recruitment and TGF--
mediated programming for TRM differentiation. A genetic interaction screen identified mitochondrial enzymes Me3
and Acss1 as putative targets that orchestrate metabolic adaptation and TRM formation under Flcn-associated
lysosomal dysregulation, thereby establishing inter-organelle communication as a driver of this process. Our
central hypothesis is that lysosomal signaling nodes integrate nutrient and immunological signals to
program long-lived TRM cells, and targeting such signaling nodes is an innovative strategy to enhance
the quantity and quality of TRM cells for tissue immunity. Our model represents a major advance in
establishing an interplay between nutrients, organelle signaling and immunological pathways that dictates
metabolic adaptation and tissue immunity and points to new avenues to improve TRM responses and tissue
immunity. Aim 1. Establish the molecular and functional effects of lysosomal signaling nodes in TRM development.
Aim 2. Define the intersection of nutrient and immunological signals for TRM differentiation and trafficking. Aim 3.
Dissect mechanisms of metabolic and nutrient adaptation for TRM development. Despite the recent interest in
immunometabolism, the function and mechanism of nutrient signaling and metabolic adaptation in TRM
biology remain poorly understood. Building upon our expertise and innovation that combine T cell biology,
mouse genetics, functional genomics and systems biology approaches, we predict our studies will establish a
new paradigm by addressing fundamental questions in TRM biology and immunometabolism, with potentials for
translation into innovative therapeutic strategies.

Public health relevance
Project Narrative/Relevance Statement Tissue-resident memory CD8+ T cells (TRM) are crucial for the frontline defense against pathogen infection and maintenance of tissue homeostasis. Our ability to harness this population to enhance therapeutic efficacy is limited, as how T cells are fated for TRM development and targeted for residency in specific tissue sites remains poorly understood. We reveal lysosomal signaling and nutrient pathways as novel negative regulators of TRM responses and tissue immunity, and a better understanding of these pathways for TRM cell biology is essential for our efforts to treat infection and immunological disorders.